Defining the biologic and physiologic trajectory of presymptomatic through advanced pulmonary fibrosis

PROJECT SUMMARY/ABSTRACT
Pulmonary fibrosis (PF) is prevalent among 200,000 persons in the USA, a figure that is increasing. Most
individuals present with progressive dyspnea and/or cough, and have moderately advanced disease with
irreversible fibrosis at the time of diagnosis. Treatment of PF at an earlier (pre-clinical) stage would result in a
greater reduction in the overall burden of morbidity, but limited understanding of the early natural history,
including the biological and clinical progression, remains a barrier to accomplishing this goal. To improve the
understanding of the earliest stages of PF, >450 asymptomatic relatives of persons with familial PF have
undergone serial screening high resolution CT (HRCT) scans to detect pre-clinical PF, as part of an ongoing
prospective cohort study. When defined by the new development or progression of abnormal changes of the
pulmonary parenchyma (“interstitial lung abnormalities” [ILA]), pre-clinical PF is observed in approximately
20% of participants. While having ILA on the first screening HRCT is a major risk factor for progression, almost
half of pre-clinical PF comprised new development of ILA, underscoring the need for additional biomarkers of
early disease. Altered gene expression in the peripheral blood precedes pre-clinical progression in this cohort,
and may represent a promising biomarker. Clinically, among those participants progressing through pre-clinical
PF (toward clinically-diagnosed PF), the observed pattern of progressive physiologic decay appears to be
disease stage-specific and occurs in a manner that may be shared across individuals with PF. Importantly, the
forced vital capacity (FVC) undergoes very little change during pre-clinical PF. The FVC is used to monitor for
PF progression and has been the primary endpoint in successful trials of disease modifying therapy for PF.
Therefore, alternative endpoints/outcome measures are needed in order to study disease modification in pre-
clinical PF. The overall hypothesis is that PF follows a sequenced progression, including blood biomarkers
(transcriptomic and/or proteins) indicative of early pathobiology and predictive of pre-clinical progression, and a
stage-specific, sequenced decay in key physiologic parameters. The following Specific Aims are proposed: (1)
Define a blood biomarker signature to predict progressive pre-clinical PF; and (2) Develop a disease
progression model (DPM) to describe the physiologic decay across all stages of PF. Disease-specific DPMs
have been used to measure disease modification such that detection of a treatment effect is subject-specific, a
more powerful alternative to analysis without regard to stage-specific progression expectations. The working
hypotheses will be tested during continued observation of the prospective pre-clinical PF cohort and several
cohorts of patients with established PF. Completion of these Aims is an important step toward a long-term
programmatic goal (of the investigators and the NHLBI) to speed development of new disease modifying
therapy for PF, particularly those capable of preventing or delaying symptom onset.

Public health relevance
PROJECT NARRATIVE Pulmonary fibrosis often presents when patients have reached an advanced stage with irreversible symptoms and lung damage. Identifying and treating pulmonary fibrosis at an earlier stage of disease would have a greater impact on reducing the burden of morbidity and mortality, but limited understanding of the biological and clinical progression during early (pre-clinical) disease precludes development of treatments capable of stopping or delaying the onset of symptoms. This project will identify biomarkers that precede the onset of symptoms and develop new disease progression modeling, both of which will improve our ability to treat pulmonary fibrosis during the pre-clinical stage.